Use of Correlated Data Methods in Ophthalmology

Project Summary / Abstract
Some exposures in ophthalmology may not have an immediate effect, but instead a lag is necessary. For
example, there is a literature on possible cataractogenic effects of corticosteroid eyedrops (CS) among uveitis
patients. However, the precise impact of dose and/or duration of use are unknown. Also, the lag between CS
administration and development of cataract is unknown. Another possible application is to study the effects of
dietary and/or supplement use on development of AMD, where a lag effect is also likely to occur. The goal of
specific aim 1 is to use latency analysis methods for ophthalmological endpoints. Latency methods have been
used in pharmacoepidemiology, but to our knowledge, have never been used for ophthalmologic endpoints.
The AREDS study was a landmark study in the epidemiology of AMD. A byproduct of this study was the
development of the AREDS severity scale which is an ordinal scale ranging from 1 for no AMD to 9+ for
advanced AMD (AAMD). The usual analysis for risk factors is a time-to-event analysis based on the Cox
Proportional Hazards Model, where the event is reaching grade 9+. This is a valid, but inefficient analysis.
There are many eyes (about 40%) which show changes (either an increase or decrease), but which don't
develop AAMD. There are risk factors which are associated with these changes, but all such changes are
treated as censored data and are considered “non-events”. In Aim 2, we propose to use an ordinal regression
model for changes between successive visits which would provide a more efficient use of the data. There have
been previous multi-state ordinal models proposed, but separate models are fit for each possible transition and
are not integrated into an overall assessment of risk for specific covariates. This has application not only for
AMD, but also for other ordinal scales used for other ophthalmologic conditions, such as diabetic retinopathy.
For Aim 3, we propose to continue our work on applying correlated data methods to risk prediction for
endpoints such as AUC. We will specifically compare methods for estimating AUC for small samples, extensive
numbers of tied prediction scores and presence of both bilateral and unilateral subjects. In addition, we will
incorporate clustered data methods for estimation of NRI, which to our knowledge, has never been done
before.
In Aim 4, we will continue our work on translation of clustered data methods for the eye research community
including (a) correlated data methods in survival analysis, (b) analysis of longitudinal binary ocular data, and
(c) sample size/power calculations based on the eye as the unit of analysis.

Public health relevance
Project Narrative This proposal will consider (a) latency (lag) effects of both harmful and beneficial effects of exposures in ophthalmic studies (b) ordinal regression models to assess change in ordinal scales in longitudinal ophthalmic scales, such as the AREDS severity scale as an alternative to survival analysis to precisely capture changes in disease severity before a final endpoint (e.g., advanced AMD in studies of macular degenration, or total blindness in studies of diabetic retinopathy) is reached (c) assessment of measures of discrimination and risk reclassification when comparing risk models in ophthalmology using the eye as the unit of analysis, and (d) translational work on clustered data methods for the eye research community with a focus on (a) survival analysis, (b) binary longitudinal outcome data and (c) sample size/power estimation.